Administrative Core

AC Summary Abstract
The Administrative Core (AC) will provide essential support and coordination to the other Cores and Projects of
the Study on Interactions between SARS-CoV-2 infection and Ancestral genomic Variations in the Risk of
Alzheimer's Disease (ISAVRAD). The AC will oversee the entire scientific direction of the U-19, manage its
resources, and integrate the scientific research activities of the four Projects with the service activities of the six
Cores. Operationally, the AC, in collaboration with the Clinical Core, will manage the transfer of samples from
collection sites to the pertinent Cores, manage relationships between the sequencing centers and DNA
repositories, oversee compliance and harmonization at international sites, and coordinate the activities of the
Cores, including their data/materials exchanges with the scientific Projects. Five established committees will
oversee the activities of the AC: Leadership, Long- Term Planning, Scientific Administrative, Fiscal &
Management Oversight, and Publications. The aims of the AC are four-fold. First, we will manage the ISAVRAD
and its internal relationships with the leaders of the Cores and Projects, including the leaders at the 5 data
collection sites. Specifically, the AC will establish and revisit timely program priorities, optimize the sharing of
resources among Cores and Projects, review data and specimen management needs, communicate scientific
advances, promote scientific relationships and collaborations with other aging programs within the ISAVRAD
network, and oversee ethical and legal issues (IRB etc.). Second, the CC will manage ISAVRAD relationships
external to ISAVRAD, including communicating with the External Advisory Committee members,
communicating, coordinating and collaborating with other aging studies to identify new and emerging areas of
scientific inquiry relevant to the goals of ISAVRAD; oversee the preparation of annual progress reports for the
National Institute on Aging; oversee the sharing of resources with investigators at outside institutions (e.g.,
data/material usage agreements); promote outreach to community residents at all recruitment sites to
disseminate current topics on health, ADRD, and lifestyles, and disseminate scientific findings to the research
community. Third, the AC will work with the Clinical, Neuroimaging, and Data Management and Statistics
Cores to ensure harmonization of recruitment, data collection, data storage and management, and
data/materials transfers throughout the ISAVRAD consortium. Fourth, the AC will oversee faculty development
activities at each academic center affiliated with this U-19, including structured in-person mentoring and
attendance at meetings/conferences.